Drug interactions involving psychoactive drugs

Commonly-used psychoactive prescription drugs such as opioids, antidepressants, benzodiazepines, and
muscle relaxants are associated with unintentional traumatic injury—a major cause of morbidity, disability, and
death. Given the increasing use of psychoactive prescription drugs, upsurge in persons with multiple chronic
conditions, growth of polypharmacy, and aging of the US population, drug interactions are a major contributor
to psychoactive drug-induced unintentional traumatic injury. Drug interactions cause significant preventable
patient harm and represent a serious public health problem, especially in older adults, since age and
polypharmacy are major risk factors. Known drug interactions are responsible for 13% of evident adverse drug
events (ADEs) and 5% of hospital admissions in older adults, and >25% of community-residing elders will, in
their lifetime, experience a clinically-significant ADE due to an interaction. Further, the risk of drug interactions
is not limited to older adults, as one in four Americans has multiple chronic conditions, which drive
polypharmacy. Therefore, the clinical and public health burden of drug interactions will continue to grow if not
curtailed.
This project's broad objective is to produce clinically-actionable and biologically-relevant knowledge
about which medications interact with psychoactive prescription drugs to increase the risk of unintentional
traumatic injury, as well as elucidate dose-response effects, duration-response effects, and subgroups most
susceptible to the interactions. We will achieve this objective by: i) conducting high-throughput automated
screening of longitudinal healthcare data to identify potential drug-drug and drug-drug-drug interactions
involving opioids, antidepressants, benzodiazepines, and muscle relaxants that increase the risk of
unintentional traumatic injury; ii) convene a multidisciplinary Expert Panel to review screening results, prioritize
signals for further investigation, and set a priori hypotheses buttressed by putative mechanisms; and iii)
conduct a series of rigorous pharmacoepidemiologic studies to inform causal inferences and thereby generate
clinically-actionable evidence on drug interactions to prevent instances of unintentional traumatic injury.

Public health relevance
Most older adults take five or more medications and are therefore at high risk for clinically significant drug interactions, a major clinical and public health burden. Medications that act in the brain are commonly used in persons of advanced age and have a high potential to cause side effects (e.g., sleepiness, dizziness) leading to unintentional injury, especially in the setting of drug interactions. This study will produce clinically-actionable and biologically-relevant knowledge about which drugs interact with four major classes of psychoactive medications (i.e., opioids, antidepressants, benzodiazepines, and muscle relaxants) to cause unintentional traumatic injury, as well as the time-course of such interactions and the subgroups of persons most susceptible to these interactions.